THERAPEUTIC TARGETING OF THE GABAA CHANNEL ON AIRWAY SMOOTH MUSCLE

DESCRIPTION (provided by applicant): Asthma is a chronic inflammatory disease of the airways whose global prevalence has taken on pandemic proportions. Although research has made great strides in elucidating the underlying mechanisms involved in asthma, in recent decades relatively few new additions have been made to the pharmacological armamentarium for this disease. Our laboratory has made several novel discoveries: (1) that 3-aminobutyric acid subtype A (GABAA) GABAA channels are expressed on airway smooth muscle cells, (2) that an endogenous GABAergic ligand-receptor system exists in the airway (3) that activation of endogenous airway smooth muscle GABAA channels potentiates relaxation, (4) that GABA (endogenously present in the airway) functions to modulate airway smooth muscle tone, (5) that systemic administration of a GABAA channel agonist administered in vivo attenuates agonist-induced airway constriction and that (6) part of propofol's broncho-relaxant effect is mediated by GABAA channels on airway smooth muscle. Since pharmacologic specificity of ligands/agonists directed at the GABAA channel is dictated by GABAA subunit composition, selective targeting of certain subunits restricted to a given tissue hold promise for improved therapy. Therefore, the goal of this research proposal is to elucidate the importance of airway smooth muscle GABAA channel subunit composition on the modulation of airway smooth muscle tone. The proposed experiments hold promise for determining how airway smooth muscle GABAA channel subunit heterogeneity can be harnessed to optimize relaxation of airway smooth muscle without promoting excessive sedation by globally activating all GABAA channels. The central significance of this proposal is the identification of a novel therapeutic mechanism to relax constricted airway smooth muscle following irritant induced bronchoconstriction. However, this work has the therapeutic potential to broadly impact the control of airway smooth muscle tone in the management of asthma and COPD. The specific therapeutic targeting of GABAA subunits expressed on airway smooth muscle coupled with traditional aerosol delivery methods to the airway, holds promise for a fundamental improvement in the pharmacologic therapy of asthma, a disease lacking in substantial improvements in drug therapy for several decades. This award will allow me to obtain the necessary investigational skills, experimental knowledge base, and fertile collaborative relationships to develop into a successful and independent clinician scientist.

Public health relevance
PUBLIC HEALTH RELEVANCE: The central significance of this proposal is the identification of a novel therapeutic mechanism to relax constricted airway smooth muscle. This work will harness the underutilized ability of anesthetics to allosterically enhance endogenous airway GABA effects at the airway smooth muscle GABAA channel. This proposal builds upon previous work from our laboratory identifying a limited repertoire of GABAA subunits comprising functional GABAA channels expressed on airway smooth muscle cells. The pharmacologic specific targeting of GABAA subunits expressed on airway smooth muscle coupled with traditional aerosol delivery methods to the airway, holds promise for a fundamental improvement in pharmacologic therapy of asthma, a disease lacking in substantial improvements in drug therapy for several decades. Narrative The central significance of this proposal is the identification of a novel therapeutic mechanism to relax constricted airway smooth muscle. This work will harness the underutilized ability of anesthetics to allosterically enhance endogenous airway GABA effects at the airway smooth muscle GABAA channel. This proposal builds upon previous work from our laboratory identifying a limited repertoire of GABAA subunits comprising functional GABAA channels expressed on airway smooth muscle cells. The pharmacologic specific targeting of GABAA subunits expressed on airway smooth muscle coupled with traditional aerosol delivery methods to the airway, holds promise for a fundamental improvement in pharmacologic therapy of asthma, a disease lacking in substantial improvements in drug therapy for several decades. __SpecificAimsTextDelimiter__ THERAPEUTIC TARGETING OF THE GABAA CHANNEL ON AIRWAY SMOOTH MUSCLE Background: Asthma is a chronic inflammatory disease of the airways whose global prevalence has taken on pandemic proportions.1 Although research has made great strides in elucidating the underlying mechanisms involved in asthma, in recent decades relatively few new additions have been made to the pharmacological armamentarium for this disease. Our laboratory has made several novel discoveries: (1) that γ-aminobutyric acid subtype A (GABAA) GABAA channels are expressed on airway smooth muscle cells2, (2) that an endogenous GABAergic ligand-receptor system exists in the airway3,4 (3) that activation of endogenous airway smooth muscle GABAA channels potentiates relaxation5, (4) that GABA (endogenously present in the airway) functions to modulate airway smooth muscle tone6, (5) that systemic administration of a GABAA channel agonist administered in vivo attenuates agonist-induced airway constriction7 and that (6) part of propofol's broncho-relaxant effect is mediated by GABAA channels on airway smooth muscle6. Since pharmacologic specificity of ligands/agonists directed at the GABAA channel is dictated by GABAA subunit composition, selective targeting of certain subunits restricted to a given tissue hold promise for improved therapy. Therefore, our goal is to elucidate the importance of airway smooth muscle GABAA channel subunit composition on the modulation of airway smooth muscle tone. We previously demonstrated that human airway smooth muscle expresses a limited, yet highly conserved repertoire of GABAA channel subunits (including α4, α5, β3, γ2 and δ)2. This limited repertoire of subunits is advantageous, as it may allow for highly selective targeting of GABAA channels expressed on airway smooth muscle. Specific Aim #1: To examine the relative contribution of α4 versus α5 subunit containing GABAA channels on membrane potential and calcium mobilization in human and murine airway smooth muscle cells using GABAA ligands and the intravenous anesthetic propofol: A. We will use dissociated airway smooth muscle cells from wildtype, GABAA α4 and GABAA α5 knock out mice to assess how genetic deletion (of either α4 or α5) alters GABAA channel responsiveness using isolated whole cell patch clamp, fluorescent membrane potentiometric probes, and calcium dye assays. B. We will engineer human airway smooth muscle cells with subunit compositions to mimic the wild type state using either α5β3γ2L or α4β3δ to assess how selective over-expression of these GABAA channels influences sensitivity to GABA, GABAA agonists, and the intravenous anesthetic propofol by using isolated whole cell patch clamp, fluorescent membrane potentiometric probes, and calcium dye assays. Specific Aim #2: To investigate the functional importance of α4 versus α5 containing GABAA channels on contraction of intact human and murine airway smooth muscle: A. We will assess how activation of endogenous GABAA α4 or GABAA α5 on intact human airway smooth muscle in vitro with agonists selective for either α4 or α5 containing GABAA channels differentially attenuate muscarinic mediated increases in airway smooth muscle tone. B. We will perform in vivo comparisons of airway resistance following methacholine challenges between wildtype, GABAA α4, and GABAA α5 knock out mice in the presence and absence of GABAA agonists, GABAA antagonists, and propofol.